Core 1: Biostatistics and Bioinformatics

ABSTRACT
The Biostatistics and Bioinformatics Core B will centralize biostatistics and bioinformatics
services and will provide support in genomic data processing, analysis, interpretation, and
compute infrastructure, as well as experimental design of laboratory experiments and validation
studies, as needed by the Projects and other Cores to achieve their Specific Aims. The
Research Projects in this PO1 require a broad range of statistical and bioinformatics expertise
and the Core provides a team of dedicated personnel to support genomic profiling studies,
including mutation detection and allele-specific copy number analysis from DNA sequencing
data, RNA-Sequencing data processing and analysis, maintenance of high-performance
computing storage, and design of pre-clinical and validation studies.

Public health relevance
NARRATIVE The overall goal of the Biostatistics and Bioinformatics Core B is to ensure streamline services in genomic data processing, analysis, storage, and design of laboratory experiments and validations, and to assist the PO1 investigators in their achievement of their overall research objective: developing new targets for therapy for carcinomas of the lung.